National Conference on Tobacco or Health

The IAA pays CDC administrative overhead for the IDDA between NCI and CDC that supports activities related to the National Conference on Tobacco or Health (NCTOH). The National Conference on Tobacco or Health is one of the largest, long-standing gatherings for top United States tobacco control professionals. The convening attracts a diversity of public health professionals committed to best practices and policies to reduce tobacco use—the leading preventable cause of disease and death in the United States.